Non-B DNA and Genome Evolution

PROJECT SUMMARY
Despite the availability of efficient technologies and rapidly accumulating data, the function and mutation
characteristics of many regions of the genome remain enigmatic. One way to solve this puzzle is through the
lens of evolution. The Makova Laboratory uses a combination of experimental and computational techniques to
study human genome evolution. The overarching goals are to decipher the mechanistic and evolutionary
processes generating genome variation and shaping genome architecture and to uncover the function of, and
selection acting on, different parts of the genome. During the next five years, the laboratory’s focus will be on
decoding the role of non-canonical (non-B) DNA structures in genome evolution. At certain sequence motifs,
DNA is capable of assuming conformations that are different from the classical right-handed double-helix with
10 base pairs per turn (i.e. B DNA). Such motifs constitute as much as 13% of the human genome. Non-B
DNA structures include G-quadruplexes, cruciforms, DNA triplexes, and Z-DNA. Their formation is transient. It
is sensitive to signals during cell differentiation and development and can b triggered by certain conditions in
the cell, including oxidative and replication stress. Non-B DNA motifs are present across the tree of life, and
abundant experimental evidence indicates non-B DNA structure formation in mammalian cells. Non-B DNA
structures can be viewed as a double-edged sword. On the one hand, their transient formation regulates a
multitude of fundamental molecular processes, including the initiation of transcription and of replication. On the
other hand, such structures may impede replication, causing increased mutagenesis and chromosomal
rearrangements. At present, it is not well understood how non-B structures evolve and influence genome
evolution. Of particular interest are the following questions. Do non-B DNA structures affect the progression of
replication forks in living cells? Do non-B DNA structures elevate rates of mutations in germline cells and thus
serve as mutation hotspots in evolution? Where in the genome do non-B DNA structures evolve under
purifying selection and thus are functional? How do evolutionary changes in non-B DNA structures affect their
functions? To address these and other questions, we will use specialized experimental and computational
approaches and will exploit the complete, telomere-to-telomere, human and ape genome assemblies. These
assemblies and approaches will provide a unique opportunity to study non-B DNA structures, which can serve
as versatile switches and fine-tunable regulators of variation in molecular processes at different evolutionary
time scales—among individual humans, among ape species, and beyond. Addressing the questions of the
proposal will illuminate the mechanisms generating human genetic variation, will assist in accurate construction
of models in population genetics and molecular evolution, will bring us closer to complete functional annotation
of the genome, and, in the future, will inform personalized medicine.

Public health relevance
PROJECT NARRATIVE Non-canonical DNA conformations play dual roles in the cell: they regulate multiple molecular processes, but may also represent hurdles for DNA replication. As a result, non-canonical DNA conformations have been associated with several neurodegenerative diseases, including Amyotrophic Lateral Sclerosis, and are the preferred sites of chromosomal rearrangements in cancer. The studies of non-canonical DNA conformations will advance our understanding of their role in disease etiology and will inform the development of personalized disease treatments.